Indoleamine 2,3 Dioxygenase in Colitis Associated Cancer

DESCRIPTION (provided by applicant): This proposal describes a 5-year training program for the development of an academic research career in gastroenterology. The PI has previous experience in laboratory investigation and is fellowship trained in gastroenterology with a focus in the inflammatory bowel diseases. He is currently expanding his scientific skills in investigation of intestinal inflammation, particularly as it relates to inflammation associated carcinogenesis. Dr William Stenson, an internationally recognized expert in laboratory investigations in intestinal inflammation has an established record of training independent scientists and will provide principle mentorship. To further promote the investigator's scientific development an advisory committee comprising of highly regarded physician scientist with expertise in intestinal inflammation as well as cancer and epithelial cell biology has been established. The research environment at the PI's institution provides a rich network of intellectual and investigational resources to support career development. The proposed research focuses on an enzyme with recognized immunomodulatory properties, Indoleamine 2,3 Dioxygenase (IDO), and its role in chronic intestinal inflammation and inflammation-associated colon-rectal cancer (CRC). The inflammatory bowel diseases and their complications lead to significant morbidity in affected individuals and their families. Colitis associated cancer is one of the most feared complications. Several lines of evidence suggest a role for IDO in these processes; however the area remains largely unexplored. IDO is seen as acting through the inhibition of lymphocyte activation. Our evidence shows that IDO is highly expressed in gut epithelial cells in response to inflammation and toll-like receptor activation. This expression of IDO in epithelial cells serves a protective function in dextran sodium sulfate colitis, a model of epithelial dysfunction which is T-cell independent. The goal of these studies is provide critical insight into the T-cell dependent and epithelial cell dependent functions of IDO in chronic colitis and colitis associated colon cancer, clarifying the potential role of therapeutic agents directed at affecting IDO activity in both colitis and malignancy of the colon. Scientific tools including knockout and transgenic mouse lines will assist in addressing the specific aims including 1) Evaluating the role of IDO in both T-cell dependent and independent models of chronic colitis 2) Determining the role of IDO in colon epithelial and cancer cell proliferation, and 3) Defining T-cell dependent & independent functions of IDO in a model of colitis associated cancer. The larger goal of the applicant and this mentored research grant is to develop the knowledge and skill sets required to become an independent investigator and ask relevant basic questions in mucosal immunology that aid in our understanding of human inflammatory diseases of the gastrointestinal tract.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of these studies is provide critical insight into the lymphocyte dependent and epithelial cell dependent functions of IDO in chronic colitis as and colitis associated colon cancer as occurs in human Crohn's and Ulcerative Colitis. The relevance of this work is to clarifying the potential role of therapeutic agents directed at affecting IDO activity in both colitis and malignancy of the colon. Project Narrative The goal of these studies is provide critical insight into the lymphocyte dependent and epithelial cell dependent functions of IDO in chronic colitis as and colitis associated colon cancer as occurs in human Crohn's and Ulcerative Colitis. The relevance of this work is to clarifying the potential role of therapeutic agents directed at affecting IDO activity in both colitis and malignancy of the colon. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Indoleamine 2,3 Dioxygenase (IDO) is a enzyme with immunomodulatory properties. In chronic intestinal inflammation and inflammation-associated colon-rectal cancer (CRC) the role of IDO is largely unexplored even though there are multiple lines of evidence suggesting a role for it in these processes. The gut is the site of the highest level of IDO expression. IDO is one of the most upregulated genes in human IBD and in mouse models of colitis. Moreover IDO inhibition increases the severity of murine experimental colitis, and agents that upregulate IDO diminish colitis severity in these models. IDO expression has also been identified in colon cancer cells. In addition to yielding new insights into the role of IDO in intestinal inflammation and inflammation-associated CRC, these studies will explore a novel aspect of IDO biology. IDO is seen as acting through the inhibition of lymphocyte activation. Our evidence shows that IDO is highly expressed in gut epithelial cells and that epithelial cell IDO is upregulated in response to inflammation and toll-like receptor activation. We have also demonstrated that when IDO is upregulated in dextran sodium sulfate (DSS) colitis, a model of epithelial dysfunction which is T cell independent, it lessens the severity of injury. A major thrust of this proposal is to define the relative contributions of T-cell dependent and epithelial cell dependent effects of IDO in chronic colitis and colitis associated cancer. Central hypothesis: In chronic colitis, IDO functions to limit disease activity through both T-cell dependent and epithelial cell dependent mechanisms. However, in colitis associated cancer (CAC), the functions of IDO become pathogenic by directly promoting epithelial cell proliferation and enabling evasion of tumor immune surveillance through inhibition of T-cell responses. Significance: These studies will provide critical insight into the T-cell dependent and epithelial cell dependent functions of IDO in chronic colitis & colitis associated colon cancer, clarifying the potential role of therapeutic agents directed at affecting IDO activity in both colitis and malignancy of the colon. AIM 1: Determine the role of IDO in chronic intestinal injury and inflammation: Hypothesis: In chronic colitis IDO functions to limit disease severity by supporting tolerance and epithelial proliferation/repair. We have shown that upregulation of IDO limits severity in both a T-cell associated and a T-cell independent model of ACUTE colitis. To determine how IDO activity impacts chronic colitis associate cancer, it is necessary to first understand how IDO affects CHRONIC intestinal injury and colitis. Using a novel mouse we generated with transgenic IDO overexpression (IDO Tg), an IDO knockout (IDO KO) mouse, we will address the hypothesis in a model which is clearly T-cell driven and a model which develops independent of T-cells. A) T-cell transfer colitis: Assess IDOs capacity to limit disease severity by altering T-cell populations B) Chronic Dextran Sodium Sulfate (DSS) colitis: Assess IDOs capacity to limit colitis severity in a model of repeated epithelial cell disruption in mice with and without intact adaptive immune systems. 1. Immunocompetent: Using WT, IDO KO, IDO Tg mice tests model with intact T-cells 2. Immunodeficient: Using RagKO, Rag/IDO DoubleKO, RagKO/IDO-Tg mice in model lacking T-cells AIM 2: Determine role of IDO in colon epithelial and cancer cell proliferation: Hypothesis: IDO expression by epithelial tumor cells promotes proliferation independent of T-cell mediating effects. In adenocarcinomas IDO over-expression has been identified in tumor epithelial cells and cell lines, though the function of IDO in these cells is not known. Our preliminary data in the non T-cell mediated injury models, DSS colitis suggests that IDO activity protects the epithelial crypt and promotes epithelial cell proliferation. A) Analyze IDO influence on pathways of epithelial cell proliferation and apoptosis: Our prelimininary data shows IDO expression in epithelial cells at the colonic crypt's base improves crypt survival in injury. Laser capture microdissection of isolated basal crypt epithelial cells from stimulated and unstimulated WT and IDO KO will be used to examine expression of genes associated with colon cancer cell proliferation. B) Determine if over or under expression of IDO impacts colon cancer growth in-vitro or in-vivo. HCT-116 colon cancer cells express IDO at baseline and increase IDO expression in response to IFNγ. Generate HCT-116 cell lines with constitutive overexpression of IDO (transfection + GFP) or lentiviral shRNAi knockdown of IDO to examine the impact on growth parameters in the following models. 1. In-vitro: Assess morphology, migration, proliferation and apoptosis 2. Xenograft HCT-116 cells in nude mice to determine whether in absence of T-cell mediated effects, IDO expression promotes greater tumor growth, vascular invasion, proliferation or apoptosis. 3. Intra-portal hepatic metastases model to determine impact on metastatic potential and growth AIM 3: Define T-cell dependent & independent functions of IDO in the DSS/Azoxymethane (AOM) colitis associated cancer model: Hypothesis: In immunocompetent mice tumor growth and metastases will be reduced in IDO-KO but increased in IDO-Tg mice. Tumor infiltrating T-reg:T-eff ratios will positively correlate with IDO activity. In immunodeficient mice, epithelial IDO over-expression will promote increased tumor growth. A) DSS/AOM in immunocompetent WT, IDO KO, IDO Tg mice examining tumor growth & T-cell infiltrates B) DSS/AOM in T-cell deficient Rag mice crossed to IDO KO and IDO Tg mouse lines. Crypt-> + Colonic Epithelium + Dysplasia Development ? Wild Type or Transgenic IDO expression IDO Knockout or Pharmacologic inhibition with 1-MT AIM 1 A&B AIM 1 A&B Chronic Injury/ Chronic Injury/ Acute Injury Acute Injury Inflammation Inflammation ¿Epithelial Proliferation ¿Epithelial Proliferation ¿ Epithelial Proliferation ¿ Epithelial Proliferation ¿(?) T-Reg: T-Eff ¿T-Cell Response Initiation ¿ T-Cell Response Initiation ¿(?) T-Reg: T-Eff ¿Overall Damage ¿ Antimicrobial Activity ¿ Antimicrobial Activity ¿Overall Damage (with chronically stimulated IDO) (modestly worse damage) (with absence of IDO activity) Trp Kyn IDO IDO IFN-γ IFN-γ TLR9 TLR9 Partial Acute Injury Acute Injury Suppression of T-Effector CpG-ODN CpG-ODN No IDO-Mediated Activation Suppression of T- Reduces T-Reg Effector Activation; T-Reg Damage Greater Damage Ensues T-Eff T-Eff Trp IDO IDO Kyn DC DC ¿ Proto-oncogene Activation IDO ¿ Loss of Tumor IDO Suppression ¿T-Reg:T-eff allows DC immune attack on CA cells IDO ¿ Proliferation ¿ Proliferation IDO 1p Colonic ¿ Immune Surveillance ¿ Immune Surveillance DC Adenocarcinoma AE AIM 3 AE ¿ T-eff:T-reg AIM 3 ¿ T-eff:T-reg (CA) Cells Decreased Tumorigenesis Increased Tumorigenesis Epitheial Cell Dysplasia Development Model illustrating the hypothesized roles of IDO in Intestinal Injury and Colitis Associated Cancer.